Immune regulation by the gut microbiome at the maternal-fetal interface

Despite advances in prenatal and maternal care, the incidence of pregnancy complications and preterm births
remains high in the United States. Maternal immune tolerance toward the fetus is critical to promote fetal growth,
but the regulatory mechanisms underlying fetal immune cell development remain largely undefined. Interferons
are key regulators for placentation, but excessive interferon responses contribute to fetal resorption. In addition,
maternal neutropenia is frequently associated with pregnancy complications such as preeclampsia, which has
been demonstrated to affect the fetus and newborn adversely. Our understanding of the functions of neutrophils
at the maternal-fetal interface, beyond their conventional role in infection, is still very limited. The gut microbiome
undergoes drastic changes during pregnancy. However, the role of maternal gut microbiome immune tolerance
and fetal immune regulation remains poorly understood. We have developed novel techniques to isolate and
characterize placental immune cells in pregnant mice. Built upon our novel discovery of the maternal MDSC-
IFNγ axis at the maternal-fetal interface that is orchestrated by the gut microbiome, the current proposal aims to
define the role of maternal gut microbiome-driven MDSC-IFNγ axis in fetal and neonatal immune development.
Leveraging the methodologies established in our lab to isolate and profile the transcriptome of immune cells, we
will use an unbiased and comprehensive approach to fully appreciate functional changes in the fetal immune
landscape due to perturbations of the gut microbiome. The transcriptomic studies will be coupled with ex vivo
functional studies of tissue immune cells isolated from the placentas and fetal/neonatal intestines, as well as
investigation of specific gut bacteria and metabolites that drive the immune cell changes at the maternal-fetal
interface. First, we will employ an unbiased approach to profile the transcriptome of the fetal immune cells in the
fetal liver and intestine to determine the role of the maternal MDSC-IFNγ axis in the regulation of immune cell
development in these fetal tissues. Secondly, we will investigate how lacking maternal MDSCs during gestation
impacts the postnatal immune development in the intestine, and investigate immune imprinting of T cells by in
utero excessive IFNγ signaling and assess how it impacts the susceptibility to gut inflammation in the offspring.
Upon completion, these studies will have defined the role of maternal gut microbiome, via regulation of the
MDSC-IFNγ axis, shapes the fetal immune landscape and neonatal immune development in the intestine. Our
studies will identify specific fetal immune subsets that are susceptible to perturbed MDSC-IFNγ axis that could
be potential therapeutic/interventive targets. The findings from our studies will provide the framework for future
studies of targeted manipulation of the gut microbiome to modulate these immune pathways to promote fetal
immune cell development.

Public health relevance
PROJECT NARRATIVE Maternal immune tolerance is essential for fetal development, but the regulatory mechanisms underlying fetal immune cell development remain largely undefined. Built upon our recent novel discovery of the maternal MDSC-IFNγ axis at the maternal-fetal interface orchestrated by the gut microbiome, we propose a multidisciplinary approach to interrogate how the gut microbome modulates fetal immune regulation via regulation of the MDSC-IFNγ axis. The findings from our studies will provide the framework for future studies of targeted manipulation of the gut microbiome to modulate these immune pathways to promote fetal immune cell development.